Multiscale modeling of the battle over iron in invasive lung infection

PROJECT SUMMARY
Invasive aspergillosis is among the most common fungal infection in immunocompromised hosts and carries a
poor outcome. The spores of the causative organism, Aspergillus fumigatus, are ubiquitously distributed in the
environment. Healthy hosts clear the inhaled spores without developing disease, but individuals with impaired
immunity are susceptible to a life-threatening respiratory infection that can then disseminate to other organs.
The increasing use of immunosuppressive therapies in transplantation and cancer has dramatically increased
suffering and death from this infection, and this trend is expected to continue. Current therapeutic approaches
have been focused primarily on the pathogen, but a better understanding of the components of host defense in
this infection may lead to the development of new treatments against this infection, possibly in combination
with antifungal drugs.
Iron is essential to all living organisms, and restricting iron availability is a critical mechanism of
antimicrobial host defense against many microorganisms; conversely, successful pathogens have evolved
potent mechanisms for scavenging iron from the host. These mechanisms have the potential to be harnessed
therapeutically, for example with drugs that enhance the host’s iron sequestration mechanisms. The
overarching goal of this project is to develop a multi-scale mathematical model that can serve as a simulation
tool of the role of iron in invasive aspergillosis. The model will integrate mechanisms at the molecular scale
with tissue-level events and a whole-body scale capturing the role of the liver. The project brings an innovative
approach to the study of this infection, and introduces innovative features to multiscale modeling through a
novel modular software design that improves flexibility, reproducibility, and model sharing.

Public health relevance
RELEVANCE STATEMENT Invasive aspergillosis represents a major and growing health problem in the U.S. and around the world. The growing population of immunocompromised patients, combined with increased resistance to recently introduced antifungal drugs makes it urgent to develop new therapeutics, in particular those targeting the host immune response. The proposed project will develop and use advanced mathematical and computational tools, calibrated to extensive experimental data, in order to explore new potential therapeutic targets to treat this disease.